VMH SF1 neurons-originated sympathetic circuits modulating iWAT and iBAT

Summary
To combat obesity and its related metabolic comorbidities, it is necessary and significant in precisely modulating
adipose tissue functions (i.e. lipolysis, beiging, thermogenesis) which play a crucial role in the control of energy
balance and glucose homeostasis. The ventromedial hypothalamus (VMH) is a well-known satiety center in the
brain to prevent body weight gain. However, the exact mechanisms and precise circuitry through which the VMH
modulates adipose tissue sympathetic outflow and function remain incompletely understood. Literature and our
recent study show that selective stimulation of neurons expressing steroidogenic factor-1 (SF1) in VMH rapidly
increases energy expenditure and heat generation. We also find that selective stimulation of VMH SF1 neuron
projections to paraventricular thalamus (PVT) elicits minimal effects on expenditure and head generation. Our
preliminary data show that selective stimulation of VMH SF1 neuron projections to PVT increases norepinephrine
(NE) contents and the phosphorylation of lipolytic hormone-sensitive lipase (p-HSL) in the inguinal white adipose
tissue (iWAT), and stimulation of SF1 neuron projections to rostral periaqueductal gray (rPAG) increases NE
contents and temperature in the inguinal brown adipose tissue (iBAT). Our results also show that cold exposure
excites a subset of VMH SF1 neurons, revealing cold-sensitive and cold-insensitive VMH SF1 neurons. We thus
hypothesize that there are molecularly distinct subsets of VMH SF1 neurons which respectively modulate iWAT
and iBAT functions through different sympathetic circuits. We focus to study VMH SF1 neurons, PVT, rPAG,
iWAT, and iBAT. We propose to identify and characterize SF1 subpopulations and sympathetic circuits that
modulate iWAT or iBAT (Aim 1), to determine the impact of cold on VMH SF1 neurons and synapse transmission
(Aim 2), and to determine if attenuating Ca2+-permeable AMPA receptor (CP-AMPAR) and tumor necrosis factor
a (TNFa) receptor (TNFR) signal in SF1 neurons can prevent obesity in HFD-fed mice (Aim 3). Overall, our
previous studies and preliminary results have enabled us to identify and characterize SF1 neuron-originated
sympathetic circuits that modulate iWAT or iBAT functions in physiological and pathological conditions. With
innovative combined neuroscience and genetic and metabolic methods and techniques such as central and
peripheral tissue photometry, electrophysiology, cell-type selective genetic, and several transgenic mouse lines,
this research project will test several novel concepts, including previously unknown VMH SF1 subpopulations
respectively modulating iWAT and iBAT functions and differentially responding to cold, cell-type specific gene
expressions, and the roles of CP-AMPAR and TNFa signals in the VMH SF1 neurons in DIO development and
prevention. The information to be collected from a series of logical studies will provide a molecular and circuit
framework that will then allow further studies by us and other groups to further understand the mechanisms for
CNS regulations of adipose tissue function and energy metabolism as well as glucose homeostasis.

Public health relevance
Narrative Precise control of adipose tissue function is crucial in modulating energy balance and glucose homeostasis. This research project will test novel concepts that molecularly distinct subsets of VMH SF1 neurons modulate white adipose tissue lipolysis and brown adipose tissue thermogenesis through different sympathetic circuit pathways, and that Ca2+-permeable AMPA receptor (CP-AMPAR) and tumor necrosis factor-a (TNFa) signals in VMH SF1 neurons contribute to the development of high-fat diet (HFD)-induced obesity (DIO). The information to be collected from this project will reveal expression of specific genes in VMH SF1 neurons modulating iWAT or iBAT, and demonstrate that attenuating CP-AMPAR and TNFa signals in VMH SF1 neurons can be an attractive strategy for the treatment of DIO in HFD-fed mice.